Phosphoinsitide signaling in Breast Epithelial Morphogenesis and Metastasis

DESCRIPTION (provided by applicant): Since 1990, the breast cancer death rate in the United States has decreased by ~2% per year, as reported by the American Cancer Society. This impressive winning streak was made possible in large part by advances in early detection and treatment. Approximately 90% of all cancer deaths arise from metastasis formation. Understanding the underlying mechanisms of metastasis will provide clues for biomarker discovery, which could be extremely important for definitive diagnosis and personalized treatment. Establishment and maintenance of the polarized epithelial morphology is essential for the development of normal breast structure and suppression of tumor metastasis. Cell-cell interactions generally inhibit cell migration and cancer metastasis, whereas integrin signals at cell-matrix adhesions are required for migration and metastasis. Our long-term goal is to understand the molecules and mechanisms that control the morphogenesis of epithelial cells including two aspects: epithelial polarity and cell motility. Towards this aim, we have been focusing on a critical lipid kinase, named PIPKI3, that regulates both epithelial polarity and cell migration via modulating E- cadherin mediated intercellular adhesion assembly or facilitating cell-matrix adhesion turnover. PIPKI3 generates phosphatidylinositol-4,5-bisphosphate (PI4,5P2), a critical lipid second messenger for cell morphogenesis by regulating actin reorganization, cell adhesion assembly, and vesicular trafficking. However, how it is regulated is not known. We observed that PIPKI3 was re-distributed from cell-cell adhesion to cell- matrix adhesion during the epithelial-to-migratory transition when wound healing occurs, indicating this kinase may have an important role in the same morphogenic transformation during the development of metastasis. In this proposal, we will investigate the molecular mechanisms by which PIPKI3 participates in epithelial morphogenesis and cell migration/metastasis via regulating the regional levels of PI4,5P2. Using a series of complementary approaches, we will define how PIPKI3 modulates the transport of E-cadherin to the basolateral membrane, maturation of cell-cell adhesion, and facilitates cell migration when re-distributed to the cell-matrix adhesions. Investigation of the diverse cellular roles of PIPKI3 will shed light on the complicated signaling networks that contribute to breast epithelial morphogenesis and will aid in the understanding of the mechanisms of the epithelial-to-migratory morphogenic transformation and tumorigenesis. Ultimately, we hope to translate this knowledge into new strategies for detecting cells where PI4,5P2 signaling is not appropriately regulated, before they have the opportunity to develop into aggressive metastatic tumors. Furthermore, these studies will provide potent candidates for new biomarkers and cancer drug targets. The outcomes of this project will clearly benefit both basic research and clinical patient care.

Public health relevance
PUBLIC HEALTH RELEVANCE: The loss of epithelial polarization and acquisition of migratory phenotype is essential for the development of cancer metastasis, the real lethal aspect of breast cancers. This proposal is designed to understand the molecular mechanism driving the initiation and the progression of this process. By exploring the role of phospholipid signaling in the progression of cancer metastasis, we should get valuable information toward understanding the signaling networks underlying metastasis, as well as define more potent targets for cancer therapies that aim to stop or reverse metastasis. Project Narrative The loss of epithelial polarization and acquisition of migratory phenotype is essential for the development of cancer metastasis, the real lethal aspect of breast caners. This proposal is designed to understand the molecular mechanism driving the initiation and the progression of this process. By exploring the role of phospholipid signaling in the progression of cancer metastasis, we should get valuable information toward understanding the signaling networks underlying metastasis, as well as define more potent targets for cancer therapies that aim to stop or reverse metastasis. __SpecificAimsTextDelimiter__ Phosphatidylinositol-4,5-bisphosphate Signaling in Breast Epithelial Morphogenesis SPECIFIC AIMS . The epithelial-to-migratory morphogenic transformation is essential for the metastasis of all epithelial-origin cancers including breast cancer; however, the underlying mechanism remains unclear. This proposal is designed to study how the morphology and motility of breast epithelial cells are influenced by the regulated incorporation of type Iγ phosphatidylinositol phosphate kinase (PIPKIγ) at cell-cell adherens junctions (AJs) or at cell-matrix focal adhesions (FAs). PIPKIγ generates phosphatidylinositol-4,5-bisphosphate (PI4,5P2), which has been implicated in multiple events that regulate cell morphology including actin organization, cell adhesion assembly, and vesicular trafficking. We have made substantial published and preliminary observations showing that PIPKIγ 1) interacts with E-cadherin (ECD) and regulates AJ assembly in epithelial cells and 2) binds talin to facilitate migration in cancer cells. These data suggest that the regulated localization of PIPKIγ by interaction with distinct binding partners determines the spatiotemporal accumulation of PI4,5P2 to support local PI4,5P2-dependent events. Cooperation between cell adhesion assembly (including AJs and FAs) and actin reorganization is essential for the morphogenic transformation of malignant breast cells, but how this cooperation is achieved is unknown. Our observations support the central hypothesis of this proposal that PIPKIγ plays a critical role in determining the morphology and motility of breast epithelial cells by modulating AJs or FAs. We propose that the targeting of PIPKIγ to AJs supports epithelial polarization but that the redistribution of PIPKIγ to FAs facilitates cell migration. Indeed, we have found that down-regulation of PIPKIγ strongly correlates with absent or mistargeted ECD, whereas up-regulation of PIPKIγ significantly correlates with elevated Her1/Her2 expression and poor prognosis in breast cancer patients. Our proposed studies will investigate how PIPKIγ participates in the morphogenesis of normal and malignant breast epithelial cells. These studies will substantially expand our knowledge of PI4,5P2 signaling in breast tumor metastasis, which is poorly understood. This proposal will test the following related yet independent hypotheses: 1. PIPKIγ is necessary for the targeting of ECD-containing vesicles to the basolateral membrane (BLM) via a functional association with the exocyst. The BLM targeting of ECD is essential for epithelial biogenesis and cancer suppression; however, the underlying mechanism is unclear. In preliminary studies we observed that PIPKIγ associates with the exocyst, which is implicated in ECD transport to the BLM. This observation suggests that PIPKIγ functionally bridges ECD to the exocyst. We will conduct experiments to evaluate the association between PIPKIγ and the exocyst and to determine the roles of PIPKIγ in (i) the recruitment of the exocyst to the BLM, (ii) the targeting of ECD carriers to the BLM, and (iii) the membrane targeting of other lateral cargos. 2. PIPKIγ forms a functional complex with myosin VI to promote the formation of cohesive AJs. Coherent, linear AJs that result from cooperation between AJ assembly and actin reorganization are crucial for stabilized epithelial polarity and are therefore vital for cancer suppression. Our preliminary results indicate that PIPKIγ regulates the formation of cortical actin bundles underneath the BLM. Additional evidence for a functional role of PIPKIγ in AJ maturation was provided by our recent observation that PIPKIγ associates with myosin VI, which recruits vinculin to facilitate AJ maturation and is regulated by PI4,5P2. In this Aim, we will analyze the association between PIPKIγ and myosin VI and the functional consequence by determining the effect of PIPKIγ on (i) the recruitment of myosin VI and vinculin into AJs and (ii) the formation of cohesive AJs. 3. Redistribution of PIPKIγ from AJs to FAs leads to the collapse of epithelial polarity and the acquisition of cell motility. With the ability to facilitate the assembly of either AJs or FAs, PIPKIγ could promote epithelial cell migration when redistributed from AJs to FAs. In this Aim, we will (i) determine the distribution and function of PIPKIγ during the epithelial-to-migratory transformation, (ii) decipher the role of Src in PIPKIγ redistribution because Src-induced phosphorylation of PIPKIγ leads to a change in PIPKIγ binding partner from the AP complex to talin, (iii) investigate the importance of this redistribution to the development of the migratory morphology in breast epithelial cells, and (iv) test whether PIPKIγ is necessary for migration and invasion of breast cancer cells. Results from this Aim will shed light on the signaling mechanism that coordinates AJ disassembly and FA assembly to promote cell migration/metastasis. BACKGROUND AND SIGNIFICANCE . Cell adhesions determine cell motility and are critical for cancer metastasis. Over 90% of cancers initiate from epithelial cells, which usually maintain an immobile, polarized phenotype. Under certain physiological and pathological conditions, these cells lose their epithelial characteristics and become migratory. This epithelial-to-